ADVANCE VACCINE PLATFORMS FOR UNIVERSAL INFLUENZA VACCINE

Advance universal influenza vaccine candidates based on nanoparticle or other novel platforms to improve potency and breadth of the immune response against the HA and/or NA proteins.